Clinical and Translational studies in muscle disease

The overarching goal of this K24 application is to further my development as a clinical
investigator and support the training of future physician scientists. My patient oriented research
interests relate to understanding the clinical, pathologic, genetic and pathomechanistic
underpinnings of inherited and acquired forms of muscle weakness. With the support of this
grant, I will continue to perform genetic discovery of patients with muscle disease, increase our
biorepository, resolve variants of unknown significance and understand the phenotypic
spectrum of these diseases. In addition, I will increase my mentorship responsibilities of
graduate students, resident physicians, fellows and junior faculty within the neuromuscular
group and Department of Neurology at Washington University School of Medicine. Moreover, I
will learn valuable skills related to mentorship and receive training related to diversity and
inclusion. A K24 grant would protect 50% effort and relieve future clinical and administrative
responsibilities. The two interrelated aims of this proposal are 1) Resolve variants of unknown
significance in LGMD genes. 2) Perform natural history studies related to rare muscle diseases.
These aims will be achieved utilizing our existing biorepository within the Washington University
School of Medicine Neuromuscular Genetics Project and the acquisition of new patients and
patient material. Support through a K24 Midcareer Investigator Award in Patient-Oriented
Research would come at a critical time in my career as I solidify my independent research
program and increase my availability to mentor graduate students, post-doctoral fellows,
residents, neuromuscular fellows and junior faculty in translational myology. Upon completion
of this award, I will have integrated clinical trainees into our existing translational research
infrastructure and created a successful pipeline to generate the next generation of clinician-
scientists focused on muscle diseases.

Public health relevance
Inherited and acquired forms of muscle weakness lead to significant morbidity and mortality. At present, 50% of patients have variants of unknown significance in genes associated with inherited forms of muscle weakness. This proposal will develop tools to assess genetic variants for potential pathogenicity and understand the phenotypic progression of these diseases.